Evaluation of an Explicit Approach to Teach Grammatical Forms to Children with Language Impairment

Project Summary
The proposed study is a randomized clinical trial that uses a Sequential Multiple Assignment
Randomized Trial (SMART) study design. The study will directly compare the efficacy of an
innovative intervention that combines explicit and implicit approaches to a traditional implicit
treatment approach to teach true grammatical forms to children with developmental language
disorder (DLD). The study will also compare interventions that include sequences of Explicit-
added and Implicit-only treatments. Participants will include 5- through 8-year-old children with
DLD who present with significant grammatical weaknesses. In Phase 1, 155 participants will be
randomized 1:1 to an Explicit-added treatment group or an Implicit-only treatment group. Each
participant will complete 32 sessions targeting four unique grammatical forms (8 sessions/form).
In Phase 2, “Masters” will be re-randomized to receive no treatment 32 sessions of the same
treatment, or 32 sessions of the alternative treatment. “Non-Masters” will be re-randomized to
receive 32 additional sessions of the same treatment or 32 sessions of the alternative treatment.
Performance will be measured on acquisition, maintenance, and generalization probes obtained
immediately,1-, 6-, and 12- months post-intervention. The SMART study design will be used to
determine if child factors, including expressive and receptive language abilities, nonverbal IQ,
and executive function skills can reliably predict the treatment sequence that optimizes
language learning. Study results will help to determine the best sequence approach to
ameliorate grammatical weaknesses, one of the core deficits of young children with language
impairment.

Public health relevance
Project Narrative The proposed research is relevant to public health because it aims to determine the best treatment approach to ameliorate grammatical weaknesses, a core deficit, of young children with developmental language disorder. Findings from this study will help to significantly improve the clinical services offered to children with language impairment. The project is focused on improving the long-term grammatical weaknesses of children with significant language impairment and is thus, central to NIDCD’s mission to improve the lives of individuals with communication disorders.